Interagency Agreement between the National Institute of Allergy and Infectious Diseases and the Uniformed Services University of the Health Sciences Armed Forces Radiobiology Research Institute

Development of safe and effective radiological medical countermeasures remains a high priority in national preparedness, and research achievements in medical radiobiological research have applicability to medical biodefense. For example, exposure to ionizing radiation results in the disruption of cellular immune functions which leads to increased susceptibility to agents of bioterrorism, as well as infectious diseases. AFRRI will work with the NIAID to establish injury models and test medical countermeasures, to advance development of products toward FDA approval and stockpile.